RANDOMIZED TRIAL OF ZDV VS 2'3'DDI VS ZDV+DDI IN SYMPTOMATIC HIV CHILDREN

The purpose of this study is to enable a comparative assessment of effects and toxicities of both ZDV and ddI and the combination of these agents in symptomatic HIV-infected children.